Treatment of HIV-Associated Cognitive Impairment

Project Summary/Abstract: The Candidate: This is an application for a K01 award for Dr. Ana-Claire Meyer, a neurologist at the University of California, San Francisco. Dr. Meyer is establishing herself as a young investigator focused on patient-oriented clinical research on infectious diseases of the nervous system in resource-limited settings. Dr. Meyer will obtain additional research training through coursework, tutorials and practical experience in the following areas: applying state-of-the-art research and laboratory methods in tropical medicine, neurophysiology, neuropsychology and neurovirology to global health settings; designing and implementing clinical trials; and additional training in implementation science and global health. With this award, she will obtain the didactic training and mentored clinical research experience she needs to establish herself as an independent researcher and successfully compete for R01 funding. This K01 award will enable Dr. Meyer to take the next steps to achieve her long-term career goal: to become a leading researcher developing, evaluating, and implementing innovative and cost-effective interventions to diagnose and treat neurologic conditions in resource limited settings such as sub-Saharan Africa. The Environment: To support her career objectives and research plan, Dr. Meyer has assembled a multidisciplinary mentoring committee comprised of senior clinical investigators who will provide added expertise in conducting clinical, epidemiological, and translational research on HIV-associated neurocognitive disorders within an international collaborative. Her primary mentor is Dr. Richard W. Price, and her co-mentors are Drs. Gretchen Birbeck and Craig Cohen. Her developing country mentor will be Dr. Elizabeth Bukusi. Her home institution, the University of California San Francisco (UCSF), is considered one of the nation's premier health sciences, training, and research centers and has a well-established reputation in biomedical research. The Department of Neurology is a leading academic center dedicated to excellence in patient care, education and research. The HIV Neurology Research Program conducts clinical and basic science research on the effects of HIV on the nervous system and includes active collaborations with clinical HIV, virology and immunology programs. Her international collaborative site, Family AIDS Care and Education Services (FACES), is an HIV/AIDS care and treatment program based in Kenya. FACES currently provides HIV care in 83 facilities in Nyanza Province and Nairobi. As of December 31, 2010, FACES had 96,821 patients cumulatively enrolled with 37,310 patients on ART. FACES clinical sites have previous experience with research studies. In addition, FACES sites are staffed by well-trained clinicians and ancillary staff and have the necessary infrastructure and oversight to complete this study. Research Plan: We estimate that HIV-associated neurocognitive disorders (HAND) may affect nearly 188,000 individuals in Nyanza Province, Kenya, 5.5 million across sub-Saharan Africa, and 8.25 million worldwide. HAND has been associated with poor adherence to antiretroviral therapy (ART) and with higher mortality. Combination ART is the most effective treatment for HAND to date and some studies have suggested that ART with higher penetration into the central nervous system (CNS) lead to improved neurologic outcomes. However, these studies have important limitations and thus there is insufficient evidence to recommend ART with high CNS penetration effectiveness (CPE) for the treatment of HAND. The objective of this application is to determine whether it is important to treat HIV-infected individuals with neurocognitive disorders with ART with high CPE. Because of limited ART choices in Kenya, we will be able to directly compare the effects of specific ART regimens thus avoiding the limitations of prior studies. The central hypothesis is that, among individuals with HAND, ART with high CPE lead to improved neurologic outcomes as compared to ART with low CPE. We will enroll a prospective observational cohort of 200 HIV-infected ART- naïve adults with HIV-associated cognitive impairment. Aim 1: To determine the effect of common ART regimens with different CNS pharmacokinetics on the neuro-psychological performance of ART-naïve HIV infected adults with cognitive impairment in western Kenya Over a follow-up period of 48 weeks, we will determine the effect of four ART regimens on three NP measures: a composite score, the QNPZ-4, and level of impairment using common diagnostic criteria. Aim 2: To determine the effect of common ART regimens with different CNS pharmacokinetics on viral replication and inflammation in the cerebrospinal fluid (CSF) of ART-naïve HIV infected adults with cognitive impairment in western Kenya In a sub-sample of 100 individuals, we will determine the effect of ART regimens on: (1) CSF HIV-1 RNA; (2) CSF:plasma HIV-1 RNA ratio; (3) CSF WBC count; (4) CSF neopterin. We will also create a unique repository of samples for future collaborative studies. Aim 3: To determine whether there is a practice effect on the neuropsychological test battery We will re-administer our NP battery to 100 HIV un-infected individuals who we have previously studied. These specific aims logically build toward an R01 to determine the effect of ART on combined systemic and neurologic outcomes in cognitively impaired individuals in a randomized controlled trial.

Public health relevance
Project Narrative: A better understanding of which antiretroviral therapies lead to the greatest improvements in cognition among individuals with HIV-associated neurocognitive disorders could help physicians better tailor antiretroviral therapy. Ultimately, this could lead to improved cognition, functional status and health for individuals with HIV-associated neurocognitive disorders. __SpecificAimsTextDelimiter__ 10. Specific Aims We estimate that HIV-associated neurocognitive disorders (HAND) may affect nearly 188,000 individuals in Nyanza Province, Kenya, 5.5 million across sub-Saharan Africa, and 8.25 million worldwide (unpublished data).1 HAND has been associated with poor adherence to antiretroviral therapy (ART)2-6 and, though most studies are from the pre-combination ART era, with higher mortality.7-11 The impact of milder forms of HAND in the era of combination ART is less well defined.11-15 However, HAND likely still have a substantial impact in resource-limited settings such as Kenya because even small decreases in adherence or small increases in mortality are magnified in a setting of high HIV prevalence (15% in Nyanza).16, 17 Widespread use of combination ART has drastically reduced the incidence of HIV-associated dementia (HAD),18-22 though milder forms of HAND are still quite common. Combination ART is the most effective treatment for HAND to date.23-28 Although older ART regimens had high levels of central nervous system (CNS) penetration effectiveness (CPE),29 recently there has been a dramatic decrease in the use of high CPE regimens.30 As we move away from ART with high CPE for newer drugs with superior systemic efficacy and lower side effects, we may be putting our patients at risk of adverse neurological outcomes. This has been surprisingly difficult to study in developed regions because of the wide variety of available ART. Instead of direct comparisons between ART regimens, most large cohort studies and clinical trials have used a proxy score to differentiate regimens with and without activity in the CNS. However, these studies have reported mixed results. Some studies demonstrate statistically significant improvements in overall neuropsychological (NP) performance after treatment with ART with high CPE, others show improvements in only a few NP domains, others show no improvements at all.31-37 Interpretation of these mixed results is difficult-are all antiretroviral drugs equivalent with regard to their impact on cognitive impairment? Or, is the CPE score not an adequate representation of the efficacy of ART on HIV-1 infection in the brain? My long-term goal is to develop and test cost-effective treatments and interventions for infectious diseases of the nervous system that have global impact and can be implemented in resource-limited settings. The aims I propose for this K01 will address a timely and important clinical issue with global relevance. The objective of this application is to determine whether it is important to treat HIV-infected individuals with neurocognitive disorders with ART with high CPE. Paradoxically, this will be easier to study in a resource- limited setting. Because of limited ART choices in Kenya, we will be able to directly compare the effects of specific ART regimens thus avoiding the limitations of prior observational studies using proxy scores. The central hypothesis is that, among individuals with HAND, ART with high CPE leads to improved neurologic outcomes as compared to ART with low CPE. Aim 1: To determine the effect of common ART regimens with different CNS pharmacokinetics on the neuro- psychological performance of ART-naïve HIV-infected adults with cognitive impairment in western Kenya Hypothesis: ART with high CPE lead to greater improvements in NP performance I will enroll a prospective observational cohort of 200 HIV-infected ART-naïve individuals with HIV-associated cognitive impairment who are newly enrolling in HIV outpatient care at Family AIDS Care and Education Services (FACES), in Nyanza province, western Kenya. Over a follow-up period of 48 weeks, we will determine the effect of four ART regimens on three NP measures: a composite score, the QNPZ-4, and level of impairment using common diagnostic criteria. Aim 2: To determine the effect of common ART regimens with different CNS pharmacokinetics on viral replication and inflammation in the cerebrospinal fluid (CSF) of ART-naïve HIV-infected adults with cognitive impairment in western Kenya Hypothesis: ART with high CPE lead to lower levels of viral replication and inflammation in the CSF In this exploratory aim, we will select a sub-sample of 100 individuals from the cohort described above and determine the effect of ART regimens on: (1) CSF HIV-1 RNA; (2) CSF:plasma HIV-1 RNA ratio; (3) CSF WBC count; (4) CSF neopterin. We will also create a unique repository of samples for future collaborative studies. Aim 3: To determine whether there is a practice effect on the neuropsychological test battery To avoid overestimating the benefit of ART on NP performance, it is of critical importance to estimate the magnitude of the practice effect (improvement on tests due to familiarity) in healthy control groups. We will re- administer our NP battery to 100 HIV un-infected individuals who we have previously studied. The rationale for this work is that there is currently insufficient evidence to recommend high CNS penetration ART for the treatment of HAND.38 A better understanding of which antiretroviral therapies lead to the greatest improvements in cognition among individuals with HAND could help physicians better tailor antiretroviral therapy. Ultimately, this could lead to improved cognition and health for individuals with HAND. These specific aims logically build toward an R01 to determine the effect of ART on combined systemic and neurologic outcomes in cognitively impaired individuals in a randomized controlled trial.